GI HORMONES IN CHILDREN WITH CHRONIC PSEUDOOBSTRUCTION

To measure fasting and postprandial plasma concentrations of hormones (cholecystokinin, neurotensin, vasoactive intestinal peptide and somatostatin) to modulate gastrointestinal motility in children with chronic intestinal pseudoobstruction.